Systems Science and Comparative and Cost-Effectiveness Research Training for Nurse Scientists (S2CER2)

Columbia University School of Nursing (CUSON) has been a leader in preparing nurse scientists to conduct
relevant, rigorous, interdisciplinary, comparative, and cost-effectiveness health policy research for nearly a
decade to inform care delivery across the lifespan and to improve the care of vulnerable patients through our
training grant (T32NR014205) and related funding sources. Leaders, preceptors, and trainees of our program
have conducted research that has advanced nursing science and health equity. We will expand on the success
and substantial achievements of the prior 10 years with this competitive renewal entitled “Systems Science and
Comparative and Cost-Effectiveness Research Training for Nurse Scientists” (S2CER2). S2CER2 aims and
training activities are well-aligned with National Institute of Nursing Research’s commitment to supporting
nursing science focused on: a) reducing and ultimately eliminating the systemic and structural inequities that
place certain population groups at a disadvantage and impede health equity; b) developing and implementing
interventions that address social determinants of health across the lifespan; and c) designing systems and
models of care to address clinical, organizational, and policy challenges. Building upon our unique and historic
strengths, S2CER2 leverages our leadership team and excellent institutional resources, including the research
base of participating faculty, to focus on overcoming structural obstacles to health for everyone—regardless of
race, ethnicity, gender, income, or location. We will provide high-quality, innovative, and relevant training for
nurse scientists dedicated to conducting systems, comparative, and cost-effectiveness research with the goal
of increasing health equity. Given our success in recruiting and training a diverse cadre of nurses and past
program outcomes, we request 3 predoctoral and 4 postdoctoral positions. Guided by the National Institute on
Minority Health and Health Disparities Research Framework, the specific aims of S2CER2 for Years 11–15 are
to: 1. Maintain an administrative structure to support interdisciplinary systems science, and comparative and
cost-effectiveness research training to advance health equity. 2. Recruit and retain a qualified, diverse cadre of
predoctoral and postdoctoral nurses from different backgrounds, cultures, experiences, and perspectives to
conduct interdisciplinary systems science, and comparative and cost-effectiveness to advance health equity
and facilitate evidence-based practice in underserved populations. 3. Enhance the knowledge and skills of
predoctoral and postdoctoral nurse trainees in the integration of theories and methods relevant to systems
science, and comparative and cost-effectiveness to advance health equity and facilitate evidence-based
practice in underserved populations. 4. Evaluate the training program inputs, outputs, and outcomes on an
ongoing and annual basis and refine the program as needed. The need for nurse scientists trained to achieve
the focus of the S2CER2 aims is greater than ever and CUSON, with its exceptional resources, is uniquely
qualified to lead this innovative program.

Public health relevance
PROJECT NARRATIVE The “Systems Science and Comparative and Cost-Effectiveness Research Training for Nurse Scientists” (S2CER2) research training program will provide nurse scientists with knowledge and skills to conduct interdisciplinary research to advance health equity. This competitive renewal will support pre- and postdoctoral trainees to conduct research focused on a) reducing and ultimately eliminating the systemic and structural inequities that place certain population groups at a disadvantage and impede health equity; b) developing and implementing interventions that address social determinants of health across the lifespan; and c) designing systems and models of care to address clinical, organizational, and policy challenges.